Global Network for Women's and Children's Health Research

Project Summary
In total, the Site 12 Indiana University – Moi University Global Network investigative team contributed
to 160 peer-review scientific articles from 2016 - 2022. Of these, our team contributed as co-authors to
52 Global Network publications, and 108 non-Global Network manuscripts. Additional scientific
productivity from the Site 12 team during this period of time includes 3 patents and 48 scientific
presentations at international and national venues.

Public health relevance
PROJECT NARRATIVE The Indiana University-Moi University partnership will continue to serve as a site for culturally sensitive and ethical multicenter international clinical research in women's and children's health. We will maintain a Maternal- Newborn Health Registry (MNH Registry), for population- and community-based studies, and complete follow- up, through deliver and up to 6 weeks postnatal, for all currently enrolled mother-baby pairs in the MNH Registry (Kenya).